T cell Memory to Viruses

Chronic viral infections are characterized by a state of T cell dysfunction that is associated with expression of
the PD-1 (programmed cell death 1) inhibitory receptor. A better understanding of the mechanisms that
regulate CD8 T cell responses during chronic viral infection is required to improve immunotherapies that
restore function in exhausted CD8 T cells. We have recently identified a novel population of virus specific CD8
T cells that act as stem cells to maintain T cell responses during chronic infection of mice with lymphocytic
choriomeningitis virus (LCMV). These stem-like LCMV specific CD8 T cells are found in the lymphoid tissues
where they reside predominantly in the T cell zones along with naïve CD8 T cells. They act as stem cells by
undergoing a slow self-renewal and can also differentiate to give rise to the terminally differentiated CD8 T
cells that are found at the major sites of infection in lymphoid as well as non-lymphoid tissues. Most
importantly, the proliferative burst of T cells that is seen after PD-1 blockade comes almost exclusively from
this stem-like CD8 T cell subset. Our studies have been confirmed and extended by others who have found
similar CD8 T cells in other chronic viral infections of mice and also in chronic infections of non-human
primates and humans. The studies proposed in the application are now focused on understanding how these
virus specific stem-like CD8 T cells are generated and maintained during chronic infection and how this
information can be used to develop rational approaches for optimizing PD-1 directed immunotherapy. The
following specific aims are proposed to achieve these goals: Specific aim 1: To understand how the generation
and maintenance of virus specific stem-like CD8 T cells is regulated during chronic viral infection. Specific aim
2: To develop strategies for enhancing virus specific stem-like CD8 T cells and optimizing PD-1 directed
immunotherapy.

Public health relevance
PROJECT NARRATIVE Memory CD8 T cells are an essential component of protective immunity, and generating effective memory CD8 T cell populations with large quantity and superior quality is a major goal of successful vaccines against chronic viral infections. Uncovering the mechanisms that give us a better understanding of the memory T cell populations during chronic viral infection could lead to establishing new and more specific molecular targets for vaccine development and chronic viral control. !